NCI FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC) CONTRACT - FY19 FACILITIES TO A

Refurbishment and Infrastructure Projects focused on Facility Improvements within the NCI at Frederick Campus.